Instrument Design Module

The Instrument Design Module of the Center Core Grant for Vision Research provides designs,
prototypes and construction of instrumentation to support and advance innovative physiological
optics and vision research at the University of Houston. The Module includes a fully equipped
machine shop, an electronics shop, and exceptional support personnel. The Module works to
meet the needs of the investigators from consultations about design, to prototyping and
constructing of instrumentation with particular optical, electronic, and mechanical requirements.
The module also provides modifications to both laboratory-developed and commercially available
optometric/ophthalmic instruments to meet specific vision research needs in addition to repair and
maintenance of existing instruments. A unique feature of the Module is the wavefront-guided
optics section with a DAC 2X-ALM contact lens lathe for special lens needs for a wide range of
research projects including vision correction, visual perception and myopia development/control.
The Module is heavily utilized by Core investigators and collaborators. The Instrument Design
Module is supervised by Dr. Geunyoung Yoon (Borish Endowed Professor) who has two active
R01 grants funded by NEI, and more than 30 years of experience in designing and building
custom-developed optical, laser and mechanical instrumentation for his own research projects.